Functional Dissection of Metabolic-Sensing Proline Hydroxylation Pathways

Project Summary
Proline hydroxylation (Hyp) is a fundamental posttranslational modification and regulatory mechanism that are
highly responsive to the changes in cellular metabolic conditions. During tumor progression, the rapid
proliferation of cancer cells creates a hypoxic microenvironment that inhibits the hydroxyproline-mediated
degradation of HIFa proteins and activates hypoxia-response cellular pathways to promote cancer cell survival
in hypoxia. In addition to oxygen, the modification enzyme prolyl hydroxylases are also sensitive to the
concentration of iron and key mitochondria metabolites including succinate, fumarate, and alpha-ketoglutarate,
making the pathway a critical metabolic sensor in cells. Extensive studies have demonstrated that proline
hydroxylation regulates protein structural stability, protein-protein interactions, or proteasomal degradation of
substrate proteins. Despite its important roles in cell physiology and success in the targeted analysis of
individual substrates, system-wide characterization and functional quantification of the pathway have been
hindered by the lack of effective tools and strategies for site-specific identification of proline hydroxylation
targets. Our overall hypothesis and long-term goal is that systematic characterization of “proline hydroxylome”
through the development of functional proteomics approaches will lead to the mechanistic understanding of
novel Hyp-mediated metabolic regulations in development and diseases. Moving towards this goal, in the past
years, we have established HypDB for functional annotation analysis of the Hyp proteome with the
development of a streamlined workflow for systematic analysis of the Hyp substrates in cells and tissues. We
have gained extensive experience in biochemical characterization of Hyp targets, the interactome of specific
prolyl hydroxylase as well as its crosstalk with other PTM regulatory pathways. To continue our effort, we will
expand the HypDB to quantify Hyp dynamics in mouse tissues and develop functional proteomics strategies to
identify key Hyp sites in protein structural stability and prolyl hydroxylase targets. We will apply recently
developed chemical and biochemical strategies to investigate the crosstalk between proline hydroxylation and
other metabolic-sensing modifications in regulating substrate protein degradation and activity. Furthermore, we
will study the physiological significance of a new Hyp-mediated epigenetic modification pathway in regulating
gene expression and chromatin activity. Overall, we anticipate that the development and application of
functional proteomics technology for system-wide analysis of proline hydroxylation proteome will reveal novel
metabolic-sensing pathways and potentially lead to paradigm-shifting concepts in the fields of cancer,
metabolic diseases, and development.

Public health relevance
PROJECT NARRATIVE Dysregulation of hypoxia-response pathways has been widely implicated in the development of cancer and metabolic diseases. The proposed research will develop streamlined workflows to functionally characterize proline hydroxylation (Hyp), a key hypoxia and metabolic sensing pathway. The mechanistic studies will reveal novel Hyp-mediated mechanisms in regulating signaling and epigenetic gene expression with broad translational potentials in tumor progression, inflammation response, and development.